Biological and structural diversity of bacterial type IV secretion systems

Project Summary
The transmission of macromolecules across biological membranes is a fundamental process in all cells. In the
earliest studies of genetic exchange in bacteria dating back to the 1940’s, the F plasmid (then termed ‘sex
factor’) was shown to self-transfer and, through recombination, can mediate the transfer of the entire E. coli
chromosome to recipient bacteria. In the ensuing ~80 years, studies have established the broad medical
importance of F and other mobile genetic elements (MGEs) in shaping of bacterial genomes and as vectors for
dissemination of antibiotic resistance and other fitness traits among bacterial populations. MGEs also encode
conjugative pili or other cell surface adhesins, which promote intercellular contacts necessary for DNA transfer
and establishment of robust, antibiotic-resistant biofilm communities. MGEs are transmitted intercellularly
through nanomachines termed type IV secretion systems (T4SSs). The T4SSs are present in most bacterial
species, where they have functionally diversified into two large subfamilies, the DNA transfer or conjugation
systems and the ‘effector translocators’ that deliver effector proteins into eukaryotic host cells during infection.
In our 33 years of investigations, my group has identified many mechanistic and architectural features of these
nanomachines, including the first view of the translocation route for a DNA substrate through a T4SS. We have
consistently implemented emerging technologies and established collaborations to diversify our approaches,
which is especially evident from this cycle of MIRA-supported research. Collaboratively, we solved structures
of 4 model T4SSs in their native contexts of the bacterial cell envelope by in situ cryoelectron tomography
(CryoET), and we solved a structure of a large subassembly of the F-encoded T4SS at near-atomic resolution
by single-particle cryoelectron microscopy (spCryoEM). Independently, we pioneered studies of F pilus
dynamics by labeling Cys-derivatized pilins with fluorescent maleimide conjugates, systematically deciphered
contributions of F-encoded machine subunits to assembly of the translocation channel and F pilus, and probed
functions of substrate processing factors and surface adhesins in early and late stages of substrate transfer.
Moving forward, we will address three major gaps in our knowledge of these dynamic nanomachines: 1) How
are substrates recruited to and delivered into and through the T4SS channel? 2) How do T4SSs elaborate
conjugative pili and for what biological ends? 3) How do T4SSs promote formation and disassembly of ‘mating
junctions’ and how are these junctions architecturally configured? We will continue to use powerful in vivo
biochemical approaches, such as site-directed photocrosslinking, in combination with state-of-the-art super-
resolution fluorescence microscopy, in situ CryoET, and spCryoEM approaches to further probe T4SS
structure-function relationships. We anticipate our multidisciplinary and ‘team science’ initiatives will continue to
generate important new information about the architecture, biogenesis, and mechanism of action of T4SSs and
set the stage for design of intervention therapies.

Public health relevance
PROJECT NARRATIVE The bacterial type IV secretion systems are widely used by many medically important pathogens for transfer of mobile genetic elements that harbor genes for antibiotic resistance and for formation of antibiotic-resistant biofilms. These systems also are deployed by many pathogens to deliver virulence factors into the human host to aid in infection processes. The type IV secretion systems are relevant for public health as they represent novel targets for therapeutics directed to blocking antibiotic resistance spread, production of robust biofilms, and disease progression.